Revealing HIV-1 persistence in myeloid cell reservoirs

Abstract
Assessing whether myeloid cells support HIV-1 persistence in the face of effective ART represents a significant
technical challenge. As a result, there is as yet, no direct evidence that myeloid cells play any role in viral
persistence in the face of effective ART. As a consequence, research on myeloid cell reservoirs is falling into
obscurity. Infection of macrophages can only be initiated by HIV-1 variants that have the ability to use low levels
of CD4 on the cell surface. Therefore, if a functional myeloid reservoir contributes to viral persistence under
effective ART, we would predict that viremia that rebounds following analytic treatment interruption (ATI), would
contain viral variants that have a high affinity for CD4. We have developed an approach that allows identification
of low frequency macrophage-tropic variants in rebounding viremia post ATI. Through single genome
amplification (SGA), we cloned a large number of viral envelopes from plasma of individuals who underwent ATI.
When these envelopes were used to construct recombinant molecular clones, they conferred the ability to fuse
with, and replicate within primary macrophages. We believe that these results provide definitive evidence
for the existence of a myeloid cell reservoir in infected individuals on suppressive ART and furthermore,
that this reservoir contributes to viral rebound when ART is interrupted.
We hypothesize that the myeloid cell reservoir is stable, permits long term viral persistence under suppressive
ART and fuels viral rebound upon treatment interruption. To pursue this hypothesis, we propose to:
1: Assess the frequency of macrophage-tropic viruses through longitudinal sampling of rebounding
viremia post-ATI.
2: Assess the persistent nature of the myeloid cell reservoir from individuals with prolonged remission
intervals following bone marrow transplant (Boston patients) as well as sampling of rebounding viremia
from individuals who underwent sequential ATI.
3: Evaluate whether macrophage-tropic viruses have a CNS origin and whether they are less fit relative
to T tropic viruses.
This proposal will integrate clinical, virologic and molecular studies to reveal the existence of a myeloid cell
reservoir in individuals on suppressive ART and to shed light on the dynamics of this reservoir. The critical
information gained from this study will provide whether there is rationale for an expanded effort to develop
strategies to target the myeloid cell reservoir and to accelerate the path to a viral cure.

Public health relevance
Project Narrative: Antiretroviral therapy controls but does not cure HIV-1 infection. Understanding how the virus persists in the face of ART is key to designing an effective strategy with which to cure infection. We hypothesize that HIV-1 persists in tissue macrophages and we propose to reveal the presence of these reservoirs form the existence of viral variants that have acquired the necessary properties to infect myeloid cells. This would provide the catalyst for the design of strategies to clear macrophage reservoirs and increase the likelihood of curing infection.